The role of loss of Y chromosome across the prostate cancer continuum

PROJECT SUMMARY/ABSTRACT
The goal of this K99/R00 Award is to accelerate Dr. Anqi Wang’s transition to an independent investigator in
cancer and molecular epidemiology by supporting her research into the role of loss of the Y chromosome (LOY)
across the prostate cancer continuum. This impactful project will investigate LOY both in leukocytes and prostate
tumors to define its potential as a biomarker for etiology, detection, treatment, and prognosis.
Dr. Wang is a postdoctoral fellow at Harvard T.H. Chan School of Public Health (HSPH). She holds a PhD in
Genetic Epidemiology from the University of Southern California, where her work shed light on germline genetics
of prostate cancer. Her plan will leverage her previous training and focus on new directions in 1) developing
expertise in tissue-based and molecular biomarkers, 2) gaining clinical and pathological insights into prostate
cancer, and 3) advancing leadership and collaborative networks. This plan involves targeted coursework,
workshops, conferences, and mentorship from Drs. Lorelei Mucci, Philip Kantoff, Konrad Stopsack, Mitchell
Machiela, and Massimo Loda. Her training will be mainly conducted at HSPH and Dana-Farber/Harvard Cancer
Center, which provides robust networking, administrative, and educational support, supplemented with annual
visits to Dr. Machiela’s lab at the National Cancer Institute and Dr. Loda’s lab at Weill Cornell Medicine for hands-
on training in LOY detection. All mentors and advisors will guide her in faculty job applications and future grant
writing to support Dr. Wang’s transition to independence.
LOY is a common form of genetic mosaicism among men that is associated with increased all-cause mortality
and chronic diseases, including prostate cancer. However, its clinical and etiologic impact on prostate cancer
and translation has yet to be fully realized. The research will use large prospective cohorts to elucidate the
multifaceted role of LOY across the prostate cancer continuum. During the K99 phase, Aim 1 focuses on LOY
in leukocytes among cancer-free men, assessing its potential for early detection of prostate cancer and its
etiologic role in molecular subtypes and germline genetic risk. The independent R00 phase investigates LOY in
leukocytes and tumors in cancer patients. Aim 2 evaluates the impact of LOY in leukocytes on clinical outcomes,
including survival and treatment response. Aim 3 examines the impact of LOY in prostate tumors on patient
survival, and its joint effect with men's germline genetic risk and molecular subtypes.
In summary, this project will provide novel insights into LOY as a biomarker for early detection, risk stratification,
prognosis, and management of prostate cancer. This award will further Dr. Wang’s expertise in integrative
molecular biomarker analysis and inform future R01 grant applications to improve prostate cancer risk
assessments and treatment strategies, positioning her to become an independent researcher who elucidate the
molecular mechanisms of prostate cancer and translate findings into actionable strategies.

Public health relevance
PROJECT NARRATIVE This research aims to elucidate the role of Y chromosome loss (LOY) in prostate cancer etiology, progression, survival, and treatment outcomes across patient cohorts. By investigating LOY in both blood and tumor tissue, the study will shed new light on our understanding of genetic risks of prostate cancer and inform more personalized strategies for early detection, prognosis, and treatment, particularly in high-risk populations. Ultimately, this study will contribute fundamental insights into genetic alterations in cancer, supporting the development of targeted interventions and personalized treatment strategies that could improve patient care and health outcomes.